OSU as a Network Lead Academic Participating Site for the NCI NCTN

PROJECT SUMMARY
The goal of this application is to provide the infrastructure to support participation of The Ohio State University
Comprehensive Cancer Center (OSUCCC) in the scientific and clinical research activities of the NCI's NCTN
Program as a Network Lead Academic Participating Site (OSU-LAPS). Faculty from OSU are integrated into the
scientific and administrative activities, participate in meetings, manage multiple core labs, design studies, and
enroll patients in all existing adult NCTN network groups using cancer center resources to leverage group
resources. OSUCCC investigators develop and lead studies designed to enroll patients on multi-disciplinary
treatment trials as well as develop and perform correlative science related research studies, bringing special
expertise in hematologic malignancies and solid tumors. Our medical, hematologic, surgical and radiation
oncologists, transplanters, psychiatrists, pathologists, cytogeneticists, translational and basic laboratory
scientists, statisticians, epidemiologists, nurses, pharmacists, and clinical research coordinators help to frame
the clinical and basic science questions whose answers contribute to improved patient outcomes and to
understanding tumor biology. OSU-LAPS will offer innovative NCI trials to the OSU patient population, support
scientific discoveries about tumor biology, find better treatments, and augment the quality of life for patients thus
improving outcomes across the spectrum of cancers affecting adults. This comprehensive program aims to: 1)
investigate new therapeutic agents, and their toxicities in Phase I to III NCI clinical trials; 2) evaluate the efficacy
and toxicity of novel combinations based on preclinical data to exploit synergistic combinations more effectively;
3) develop multi-modal approaches using surgical, immunological, and radiotherapeutic therapies in optimal
combinations; 4) integrate experts in molecular genetics, biochemistry, pharmacology, immunology, and
biostatistics in the design and execution of therapeutic protocols; 5) improve cancer outcomes through discovery
and education of pre and post-doctoral students, nurses, allied medical personnel and physicians, 6) understand
and exploit tumor heterogeneity and the tumor microenvironment to fully exploit the value of new targeted and
immunologic therapies, 7) improve the management of cancer related symptoms, 8) form the next generation of
clinical investigators by offering them formal teaching and mentoring within the NCTN, and 9) enroll volunteering
patients on trials.

Public health relevance
PROJECT NARRATIVE This grant supports Ohio State University Comprehensive Cancer Center (OSUCCC) participation in the NCI's sponsored National Clinical Trials Network (NCTN). OSUCCC offers clinical trial participation to all eligible patients to improve prevention of cancer, discover better cancer therapies, and boost the cure rates of adults with cancer. OSUCCC has one of the largest volume academic cancer centers in the US and is fully engaged in NCTN research with each of the existing NCI supported Operation Centers, and many other NCI initiatives.